Wearable ultrasound for continuous non-invasive blood pressure sensing

Project Summary
Hypertension is a leading risk factor for disease and death in the US, contributing to over 690,000 deaths
annually. Blood pressure (BP) measurement is an essential part of a coordinated diagnosis and management
strategy. There is a longstanding need for continuous non-invasive BP measurements to reveal the daily
variations between clinic visits. Wearable devices such as smartwatches are attractive platforms for health
sensing. However, existing wearable sensors fall short because they use a light-based signal called
photoplethysmogram (PPG). While PPG biosignals are adequate for heart rate detection, their indistinct pulse
wave shapes do not encode blood pressure. A promising alternative to PPG is wearable ultrasound, which can
measure high resolution waveforms from large arteries. However, wearable ultrasound’s potential remains
untested. The central hypothesis is that wearable ultrasound sensors can accurately estimate central
blood pressure. This work aims to evaluate the central hypothesis using both simulated and experimental
data. In Specific Aim 1, the BP estimation accuracy of wearable ultrasound will be evaluated using a large
simulated dataset. An existing computational model of the arterial vasculature will be used to produce a
dataset of simulated wearable ultrasound from the radial artery in the wrist. This dataset will be used to train
convolutional neural networks to predict central BP. In Specific Aim 2, a prototype wearable ultrasound device
will be developed and used to collect an experimental dataset with human subjects. 30 healthy subjects will
wear wearable ultrasound while performing BP-altering activities including postural changes, physical activity,
and controlled breathing. To convert measured recordings to a format congruent with the simulated data of
Specific Aim 1, the experimental waveforms’ timing and shape information will be separated using a pulse
deconvolution algorithm. A convolutional neural network will then be trained to predict brachial cuff pressure.
To achieve these aims, the predoctoral fellowship applicant will conduct mentored research and training in
cardiovascular simulations, wearable sensor design, and statistical algorithms for biomedical time series
inference. The training plan includes coursework in cardiovascular simulations and statistical learning,
hands-on lab skill training, regular advising meetings, and feedback on written and oral scientific exposition. In
summary, this work combines simulated and experimental data to evaluate wearable ultrasound’s potential for
BP estimation, opening a new avenue of research towards the longstanding need for continuous non-invasive
BP sensing. Furthermore, through technical and professional skill development, the fellowship applicant will
develop as an independent researcher advancing cardiovascular health through sensors and algorithms.

Public health relevance
Project Narrative Measuring daily blood pressure is critical for understanding and reducing cardiovascular disease, but existing wearable sensors cannot accurately measure blood pressure. Wearable ultrasound, which can measure high-resolution traces of pulse waves in large arteries, may overcome limitations of existing sensors. Using both computational simulations and lab experiments, this work will evaluate the accuracy of estimating blood pressure from wearable ultrasound sensors, opening a new avenue of research towards the longstanding need for continuous non-invasive blood pressure sensing.